Cancer Research Training and Education Coordination

PROJECT SUMMARY: Cancer Research Training and Education Coordination
Evan Shereck, M.D., M.Ed., Associate Director of Cancer Research Training
The foundation of any premier cancer research center is the training and education it provides to its students,
trainees, faculty, and staff. At the Knight Cancer Institute (KCI), Cancer Research Training and Education
Coordination activities are managed by our Cancer Research Career Enhancement (CRCE) team. CRCE
develops and maintains programs and support to build a diverse, prepared cancer research workforce. The goal
of CRCE is to provide education and career enhancement activities that prepare all trainees, faculty, and staff
for sustained, productive, and fulfilling careers within cancer research. The genesis of innovation in cancer
research is collaboration and communication amongst researchers; CRCE provides the necessary structure for
these intra- and inter-programmatic interactions. CRCE activities facilitate connections for students, trainees,
and researchers within and between the KCI Research Programs and Shared Resources, which in turn
stimulates innovations in cancer diagnosis and treatment. CRCE recognizes that the best teams are composed
of diverse voices where all members feel respected and able to share their thoughts and opinions. In alignment
with the KCI Strategic Plan to support a Culture of Inclusion and Innovation, CRCE is committed to increasing
diversity and inclusion through recruitment, as well as by preparing this diverse workforce for promotion to
leadership positions. At every stage in the training continuum, our focus is on the inclusion of individuals
identifying with under-represented groups across race, ethnicity, gender identity, sexual orientation, immigration
status, language proficiency, and ability. The KCI is proud to have started many educational programs aimed at
leadership training designed especially for these populations. This included an overall investment in CRCE of
$3.6 million and $25 million towards the recruitment of faculty members identifying with an under-represented
group over the past reporting period. By supporting all students, trainees, faculty, and employees in their
professional development, CRCE enhances the ability of the KCI to achieve its mission of ending cancer as we
know it for the patients within our catchment area and beyond.